Color's software and services platform for the Return of Personalized Value to the All of Us Research Program participants

ABSTRACT
The All of Us Research Program (the Program) aims to accelerate health research and
medical breakthroughs by engaging a diverse cohort of at least one million participants
in the US. Color Health, Inc. (Color) is an organization that has been built to improve
population health by providing best-in-class diagnostic testing, scalable clinical services,
and user-centered software tools. Over the past five years, Color has developed a
custom return of results platform and provided high-quality clinical services as the
Program’s Genetic Counseling Resource (GCR). To date, Color’s software and
professional services have made results available to more than 240,000 All of Us
participants and completed more than 3,500 genetic counseling appointments. Here, we
outline our proposal to continue to support the Program as it strives to reach its goals of
recruiting and retaining one million engaged and diverse participants. In addition, we
describe our technical approach and capabilities to ensure the success of the Program
as it tackles new partner integrations, enrolls new participant cohorts, and launches
ancillary studies, all while maintaining its commitment to Return Value and Engage with
its diverse participant base.
Color's technical approach includes a robust software architecture for personalized
result generation, participant return of results, and custom tools to support Program
coordination and clinical service delivery. To ensure ongoing Engagement, Color will
develop a customizable notifications platform for tailored participant communication
strategies. Our experience in software development, regulatory compliance, and
participant-centric design ensures high-quality, scalable, and secure services, meeting
immediate Program needs and supporting future expansions, including new genomic
results and other information types.
In addition, Color will provide best-in-class professional genomics-specific support and
genetic counseling services to the Program’s culturally diverse, geographically
dispersed population, with multilingual support and accessible phone consultations. Our
culturally competent staff will deliver empathetic and appropriate services, addressing
the unique needs of the Program’s participants.
Finally, Color proposes to drive the longitudinal participant Engagement and Return of
Value strategy by providing meaningful and personal information in a sensitive and
regulatorily compliant manner. This includes gathering and incorporating input from the
diverse set of stakeholder opinions across Program Staff and partners. By ensuring that
the Program is able to provide regular touchpoints and personalized insights, we aim to
enhance the participant experience and drive long-term involvement.
Through these efforts, Color aims to advance the All of Us Research Program's ultimate
goal to help individualize prevention, treatment, and care of patients, ensuring long-term
success and contributing to groundbreaking health research.

Public health relevance
The program will have an immediate impact on public health through the provision of direct clinical services to All of Us participants, in the form of clinical genetic testing and genetic counseling for adult-onset hereditary diseases.